2025 Drug Metabolism Gordon Research Conference and Seminar

Scientists working in the field of drug metabolism and pharmacokinetics (DMPK) are integral partners in the development of new therapeutics. DMPK scientists contribute to understanding the safety profile of an investigational molecule throughout the continuum of its development. In modern R&D programs, the employment of only traditional tools and technologies can be resource-consuming, may not provide information that translates appropriately from animal models to human, and may fall short of accurately predicting human response. In this 53rd Drug Metabolism GRC, conferees will learn from and interact with experts in the areas of microphysiological systems, non-CYP enzyme mediated metabolic pathways, tools and techniques to study biotransformation, expression and function of drug transporters, regulation of drug metabolizing enzymes, challenges encountered in the support of programs to explore novel therapeutic modalities, and drug-drug interaction (DDI) considerations for people at all stages of life, including how the latest advances in our field can potentially improve therapeutic outcomes and reduce DDI risk. New drug modalities present unique challenges but are also considered opportunities for DMPK scientists to make an impact, considering our unique educational background and skill sets. High-resolution mass spectrometry (MS) has evolved over the years, and some institutions have invested in highly sensitive accelerator MS (AMS) technology. This investment brings bioanalysis of small molecules and metabolites to an entirely new level, and there will be a talk on the applications of AMS. The benefits of employing such advanced and sensitive tools in drug discovery and development programs are vast, including but not limited to reducing side effects, providing preventive health care options, optimizing the cost of new medicines, and accelerating drug development. The Drug Metabolism GRC will bring together academic, industry and regulatory scientists at all career stages, providing a stimulating and welcoming environment to discuss their latest research. The informal venue with communal dining and housing provides an ideal environment for early career scientists to interact with leaders in their respective fields, expand their knowledge, establish collaborative relationships, and consider various career paths. Scientific sessions are held in the mornings and evenings over 4.5 days with the afternoons available for informal discussions and recreation. GRC meetings are relatively small and are designed to facilitate frequent and intensive discussions during both the formal scientific sessions and informal interactions. To create and environment conducive to such interactions, the Drug Metabolism GRC will have four 2-hour afternoon poster sessions, with each poster presenter available for discussion during all sessions. The 2-day Gordon Research Seminar (GRS) will precede the main GRC conference, providing a unique environment for students and early career scientists to present their current research, connect with peers at other institutions, and obtain mentoring from established professionals.

Public health relevance
Humans inherently metabolize drugs differently, and as such it has always been challenging to identify the right drug, at the right dose, to help all patients in need of treatment. Contributing factors that result in interindividual differences in levels of drug exposure and pharmacological efficacy include pharmacogenomics, variability in diet and the resulting gastrointestinal microflora, and behavioral components such as levels of stress and physical activity. Drug metabolism scientists study these factors and contribute to the overall safety assessment of new medications, to not only enable the discovery and development of treatments for patients suffering from diseases, but also to ensure that such new medications will not adversely interact with those that are currently available and routinely prescribed.